Training in Pediatric Gastroenterology, Hepatology, and Nutrition

PROJECT SUMMARY:
The overarching goal of our Training Program is to prepare MD, MD/PhD pediatricians, and PhD scientists for
careers in independent research on topics relevant to digestive diseases in infancy, childhood, and adult life.
The rationale for our program is founded upon the idea that meaningful and strong intellectual, mentoring, and
financial support for newly emerging scientists will enable the recruitment of talented young people to our field
and foster early success in their long-term career development as effective independent investigators pursuing
meaningful science relevant to health and disease of the alimentary tract. We offer training in 4 broad areas
relevant to our field of gastroenterology: 1) Epithelial Cell and Molecular Biology - including Stem
Cell/Developmental Biology and Enteric Neurobiology; 2) Innate and Adaptive Mucosal Immunology; 3) Microbial
Pathogenesis, Gut Microbiome, and effects on Metabolism; and 4) Clinical Research. The training program
provides an in-depth comprehensive and strongly mentored scientific experience for each trainee in a research
group at the forefront of its field. Eight postdoctoral positions are requested. 35 NIH-funded highly accomplished
core research faculty support this effort, providing great depth and diversity of scientific training and over $52
million in combined current research support. Opportunities for cross-fertilization among faculty members and
their trainees are abundant.
The Program Director is Dr. Scott B. Snapper MD PhD, Egan Family Professor of Pediatrics, Harvard
Medical School, and a widely respected investigator and mentor. Program steering committee includes Drs.
Wayne Lencer MD, Meena Rao MD PhD, Jon Kagan PhD and Rachel Rosen MD MPH. An External Advisory
Board provides oversight to the program. Scholarship Oversight Committees (SOCs) are assembled for each
trainee to provide oversight (and further mentoring) in personal scientific and career development. Didactic
course work is encouraged for both basic and clinical research training and supplemented with relevant seminars
and journal clubs, a course in the responsible conduct of research, and an annual research retreat. For clinical
research trainees, the program supports matriculation through a Master’s Degree in Medical Science or Public
Heath (MMSc or MPH) from Harvard Medical School or Harvard School of Public Health.
Since 1997, 72 (70%) of our past 103 Trainees remain in academics, 20 (19%) in industry, 4 (4%) in
government (NIH/FDA), and only 7 (7%) are in clinical practice or have left academics. 18% of our past Trainees
have achieved independent NIH research awards (RO1 or equivalent), 32% have achieved NIH K-series awards,
and 57% have achieved other NIH (e.g., F32), Foundation, or other (institutional) Career Development Awards.
Our T32 training program continues to have a broad-based effort to recruit URM trainees and faculty. Importantly,
our program has populated the faculty of academic institutions across the nation and internationally.

Public health relevance
PROJECT NARRATIVE: The goal of this application is to prepare MD, MD/PhD pediatricians, and PhD basic scientists for careers in independent research on topics relevant to digestive diseases in infancy, childhood, and adult life. Post-doctoral training in both basic and clinical research relevant to the GI tract is provided.